INTRACAROTID HIGH-DOSE CISPLATIN FOR THE TREATMENT OF BRAIN TUMORS

To prevent occurrence of severe systemic toxicity, indocyanine green is injected into the patient's carotid vein immediately prior to the start of chemotherapy and is quantitated as a means of predicting drug removal by a simultaneously operated hemodialysis process. A spectrophotometric method was used for the quantitation of indocyanine green in plasma, using absorbance at 802 nm ( =802). The method was evaluated for sensitivity (1.0 ug/m1) and reproductibility (7%) and was found adequate for the planned clinical application. The dose of cisplatinum will be 220 Mg/m2 for each cycle of treatment with the hemodialysis process expected to remove about 70% of this dose.